Development of an intranasal, direct to nerve treatment for headache disorders

PROJECT SUMMARY
According to the US Centers for Disease Control, 14.2% of US adults report experiencing migraine symptoms within any
given 3-month period, making it the second most disabling illness in the world. Diagnosed migraine is typically categorized
as either episodic (2 – 14 days per month) or chronic (15 or more days per month), with each attack accompanied by a
combination of debilitating pain and symptoms that persist between 4 - 72 hours. There is no absolute cure for migraine,
and the overall financial burden associated with these disorders is more than $72B annually in the US and Europe. For
individuals affected, however, the personal “costs” go well beyond financial and physical pain and are reflected in
decreased relationship satisfaction, increased dependency on caregivers, and loss of work and social productivity. Despite
increased recognition of parasympathetic activation of the trigeminovascular system through the SPG, the majority of
acute migraine therapies target downstream effects of trigeminovascular activation, including CGRP receptors and 5-HT
receptors. Nonspecific pain medications used in migraine (acetaminophen, NSAIDs, opioids) may have a more direct anti-
nociceptive effect on the trigeminovascular system, but they either lack adequate potency for severe migraine symptoms
or cause significant adverse effects. Sphenopalatine ganglion (SPG) block procedures directly target the trigeminal nerve
and have been identified as an effective, in-clinic method for reducing migraine symptoms that can be administered as
often as needed without the potential for severe or addictive side effects. To date, these procedures have not been
considered a strong alternative to front-line medications due to their 1) Necessity for administration by a trained
healthcare professional, 2) Difficult and uncomfortable route of administration, and 3) High supply and procedural costs
compared to single-dose medication. In response to the increasing clinical need for alternative migraine therapies, our
team comprised of migraine care specialists, device and drug developers, and clinical research specialists has created a
technology for accurately delivering medication to the upper-posterior nasal cavity, enabling development of a self-
administered SPG block combination product that provides rapid pain relief without the harsh and addictive side effects
of existing medications. The Principal Objectives of this Phase I SBIR, separated into two distinct Aims, are to establish
technical efficacy and evaluate commercial design feasibility for self-administration – a critical component for treatment
efficacy. In the first aim, components affecting nasal spray characteristics will be designed and prototyped. Benchtop and
in vitro performance testing will be conducted using a surrogate nasal cast and laser diffraction techniques to measure
and optimize droplet size, distribution patterns, drug substance delivery rate, total drug substance delivered, and nasal
cavity deposition to ensure local drug application to the SPG while meeting specifications for function and safety based
on current recommendations for drug delivery devices. Aim 2 will focus on the creation of system-level designs for the
delivery device through formative human factors evaluations that will bring together diverse groups of migraine patients,
clinical care professionals, and key opinion leaders. The conclusion of Aim 2 will be an FDA pre-IND meeting to obtain
clarification on the regulatory pathway and preclinical and clinical testing to support a successful NDA application.

Public health relevance
PROJECT NARRATIVE Migraine is an extremely incapacitating collection of neurological symptoms that has been identified by the World Health Organization as the 2nd most disabling illness in the world. Oral pain medication is the most common form of migraine treatment; however, over two-thirds of migraine sufferers report being dissatisfied with their treatment options and delay or avoid taking medication due to potentially harmful and addictive side effects. We are proposing to meet the unmet need of an effective, at-home, non-addictive, migraine therapy by developing a novel, self-administered, intra-nasal combination product that translates sphenopalatine ganglion (SPG) block procedures from the clinic into the hands of patients.